The Impact of Product Formulation on the Pharmacokinetics and Pharmacodynamics of Delta-9THC-Infused Cannabis Edibles

PROJECT SUMMARY/ABSTRACT
As cannabis legalization has expanded, many novel products have emerged. Oral cannabis products (or
“edibles”) are among the most popular. Similar to traditional forms of cannabis, edibles that contain delta-9-
tentrahydrocannabinol (THC) as the primary constituent have abuse liability and can produce unwanted negative
effects (e.g., cognitive/psychomotor impairment, panicked reactions). Cannabis users often report that edibles
produce highly unpredictable effects, making these products prone to eliciting adverse events. Edibles are
responsible for most emergency room visits related to cannabis over-intoxication. Inconsistency in cannabis
edible effects likely stems, in part, from the large variety of formulations within this diverse product category.
Preclinical research has shown that THC absorption is markedly increased when ingested in lipid or
“nanoemulsion” formulations relative to non-lipid or non-nanoemulsion formulations; nanoemulsion is a process
used to make cannabinoids more hydrophilic and purportedly, more bioavailable. Thus, these formulation
characteristics may directly impact the magnitude of THC absorption and THC-related acute effects in humans.
However, controlled clinical research on cannabis edibles is limited and few studies have evaluated if the
formulation of these products influences pharmacokinetic (PK) or pharmacodynamic (PD) outcomes.
The proposed, double-blind, placebo-controlled human laboratory study will compare the PK and PD effects of
3 popular types of cannabis edibles: THC-infused chocolates, gummies, and drinks. We hypothesize that THC
absorption and resultant PD effects will be significantly greater for the chocolate (high lipid concentration) and
drink (nanoemulsion formulation) relative to the gummy (low lipid concentration and no nanoemulsion). Healthy
adults will attend 9 outpatient laboratory sessions. For each session, they will consume 1 of 3 cannabis edible
formulations (chocolate, gummy, or nanoemulsion drink) at either 0mg THC (placebo), 10mg THC, or 25mg THC
(i.e., 2 and 5 Standard THC Units, STUs); sessions will be preceded by 8 hrs of monitored overnight fasting.
Sessions will be completed in a randomized order and separated by at least 1 week. PD assessments will include
a battery of cognitive/psychomotor performance tasks and a subjective drug effect questionnaire, all shown to
be sensitive to cannabis at the proposed STUs. Blood plasma will be collected to quantify concentrations of THC
and its primary metabolites (11-OH-THC, THCCOOH). This project will determine whether the formulation of
cannabis edibles influences PK/PD effects when THC doses are held constant, which is of growing importance
given initiatives to utilize STUs for research and regulatory purposes. Data generated from this project can
potentially inform educational efforts to reduce the incidence of adverse events caused by cannabis edibles and
provide insight into whether cannabis edible formulation should be a consideration, in conjunction with STUs, for
research, regulatory, and clinical decisions.

Public health relevance
PROJECT NARRATIVE Oral cannabis products, or “edibles”, are increasing in popularity, but the effects of these diverse products are notoriously unpredictable. This study will compare the acute effects of different types of edibles (chocolates, gummies, drinks) to determine if product formulation influences the absorption of THC, the psychoactive component of cannabis, or alters acute cannabis-related subjective and cognitive effects. This project will provide important information on how cannabis edible formulation (e.g., food matrix) impacts acute cannabis effects which ultimately can reduce the incidence of adverse events associated with these products and inform future research decisions and regulatory efforts.